MARC at UAlbany

PROJECT SUMMARY
The mission of MARC at UAlbany is to add well-trained scientists from diverse backgrounds to the
biomedical research workforce. We will prepare traditionally underrepresented (UR) undergraduate students
for a successful transition into research-focused graduate programs and, ultimately, biomedical research
careers, through evidence-based didactic, research, and professional skills training. The program leverages
two key strengths of the University at Albany, namely its highly diverse undergraduate student body and its
status as an R1 “very highly research active” university. It synergizes with existing campus initiatives promoting
diversity, equity, and inclusive research excellence. Specific program objectives are to (1) recruit and retain
six well-qualified rising juniors from groups traditionally underrepresented in biomedical research careers each
year, (2) implement evidence-based strategies that synergistically promote and facilitate MARC scholars’
academic preparedness, responsible participation in mentored research, professional skills and identity, and
social and cultural capital, (3) prepare MARC scholars for the successful transition into and completion of
research-focused graduate degree programs, and (4) employ rigorous oversight and assessment strategies to
monitor program performance and outcomes. Evidence-based training activities are grounded in an
established theoretical framework for advancing UR students in biomedical sciences and impart skills
fundamental for success in research-focused graduate training programs. Coursework prepares MARC
scholars to engage in the responsible and rigorous conduct of research and guides them through the process
of applying to graduate programs. Authentic mentored research experiences, closely supervised by culturally
competent faculty with track records of research excellence and external funding, provide the basis for the
independent capstone research project and co-authorship on conference presentations and manuscripts.
MARC at UAlbany integrates existing campus initiatives and resources promoting student success in
academics and research into a structured program tailored to maximally benefit UR trainees. Importantly, we
augment ongoing efforts with program activities specifically designed to enhance trainee self-efficacy, sense of
belonging, and science identity, and to foster the cultural and social capital crucial for the successful retention
of UR students in biomedical research training and careers. Scholars’ and their mentors’ success in achieving
program objectives will be closely monitored via individual development plans, annual assessments, student
exit interviews, and yearly information gathered from program graduates. An internal advisory committee will
provide regular oversight of program implementation. Targeted measurable trainee outcomes include: (1)
90%+ of MARC scholars graduate with a bachelor’s degree with honors within three years of joining the
program, (2) 70%+ enroll in competitive, research-focused biomedical graduate programs, and (3) 80%+ of
those entering graduate programs complete the degree and enter the biomedical research workforce.

Public health relevance
PROJECT NARRATIVE MARC at UAlbany seeks to advance the mission of the NIH and the MARC program to increase the diversity of the pool of biomedical researchers working to address today’s most pressing public health concerns. MARC at UAlbany builds on the incredible diversity of the University at Albany undergraduate student body, track record of excellence in health-related biomedical research, and demonstrated institutional commitment to diversity, equity, and inclusion. A structured program of training activities coalesces and augments existing initiatives to offer students traditionally underrepresented in biomedical research careers the individualized team mentorship, academic enhancement, high-impact research experiences, professional skills development, and supportive community necessary for their successful transition into research-focused graduate (Ph.D. and M.D./Ph.D.) training programs.